Social Motility and cAMP signaling in chemotaxis and parasite-vector interactions of African trypanosomes

Project Summary Recognition of social behavior and cell-cell signaling as a ubiquitous property of bacteria revolutionized our understanding of microbiology and microbial pathogenesis. Parasitic protozoa generally are not considered in this context. Recent work however, demonstrates that the paradigm of microbes as social organisms can and should be brought to bear on questions about parasite biology, transmission and pathogenesis. African trypanosomes, e.g. Trypanosoma brucei, and related trypanosomatid parasites are responsible for substantial human suffering worldwide. T. brucei is transmitted between human hosts by tsetse flies. The parasites live in communities in which they can communicate with one another and engage in group behaviors that are not evident in individual cells, this behavior is termed “Social Motility” (SoMo) and shows analogies to social behavior in bacteria. Studies of SoMo provided insight into parasite signal transduction and chemotaxis, which are directly relevant for parasite development, transmission and pathogenesis. In the current proposal we will use recently discovered SoMo mutants to elucidate signal transduction mechanisms in trypanosomes and define gene expression programs that govern chemotaxis, social behavior and tsetse fly infection. We expect our studies will provide new perspectives and approaches for understanding parasite biology and for developing novel strategies for management and therapeutic intervention in parasitic disease.

Public health relevance
Project Narrative Trypanosomatids are protozoan parasites that cause substantial human suffering worldwide. The paradigm of microbial social behavior and cell-cell signaling revolutionized our understanding of bacterial pathogenesis and can now be applied to protozoan parasites. In the current project, we will apply these concepts to trypanosomatids to give insight into parasite signal transduction, transmission and host-parasite interactions.